DP21-001 Utah Pregnancy Risk Assessment Monitoring System (PRAMS)

Since 1999, the Utah Department of Health (UDOH) has conducted the Pregnancy Risk
Assessment Monitoring System (PRAMS) survey to help improve understanding of maternal
behaviors and their relationship to pregnancy outcomes and to develop policies and programs
to improve outcomes. Utah’s crude birth rate is the highest in the nation, and PRAMS provides
essential data that allows UDOH to address health indicators such as preterm birth, maternal
depression and anxiety, breastfeeding practices among hospitals, and preconception health
behaviors. The Utah PRAMS team includes four members, three with over five years’
experience, and the entire staff is well qualified to continue this important work. Utah PRAMS
enjoys effective cooperation with Utah’s Office of Vital Records and Statistics and is valued and
supported throughout UDOH. Utah PRAMS builds on well-established procedures, conducts
experiments to evaluate and improve response rates, and successfully translates data into
action through data dissemination reporting and collaboration on research and policy with
UDOH staff and University of Utah faculty.

Public health relevance
Utah surveys 5% of mothers of live births to collect state-specific, population-based data on maternal behaviors and experiences before, during, and shortly after pregnancy for the Pregnancy Risk Assessment Monitoring System (PRAMS), a surveillance project of the Centers for Disease Control and Prevention (CDC) and state health departments. Utah PRAMS provides a rich source of data that is used by both researchers and policy makers to improve the health of mothers and infants.